Biotechnology Training Program in Applied Life Sciences

Project Summary
The past decade has been truly transformative for the Applied Life Sciences at the University of Massachusetts,
Amherst (UMass). During this period a $150M investment in state-of-the art equipment housed in 30 core
facilities operated by PhD-level center directors and over $400M in new research buildings has revolutionized
the research capacity at our institution. This massive infrastructure growth has been matched with the hiring of
over 50 new faculty in the life sciences. During this tremendous expansion we have developed the Biotech
Training Program (BTP) in Applied Life Sciences, which leverages campus investments to provide outstanding
training to a talented group of graduate students to prepare them for careers in the Biotech workforce and related
areas. This training is guided by these objectives: 1) create a scholarly and social environment to facilitate new
and strengthen existing interdisciplinary networks at UMass, particularly those at the interface of engineering
and the life sciences; 2) educate students in the fundamentals of quantitative biotechnology through lecture and
laboratory courses; 3) train students in the commercial impact of biotechnology through a tailored industrial
internship and regular interactions with industrial personnel; 4) provide students with opportunities to improve
interdisciplinary communication, expand career opportunities, and sharpen professional skills; and 5) increase
the number of students, particularly those from underrepresented groups, who pursue careers in biotechnology.
BTP faculty are recruited not by departmental affiliation, but by membership in the Institute for Applied
Life Sciences (IALS), their research in biotechnology and their commitment to student training. For this reason,
the UMass BTP recruits students from twelve PhD programs: Biomedical/Chemical/Civil/Mechanical
Engineering, Chemistry, Microbiology, Molecular & Cell Biology, Neuroscience & Behavior, Plant Biology,
Polymer Science & Engineering and Veterinary & Animal Science. We request twelve Trainee slots (matched
with three and a half slots annually from UMass). Traineeships are awarded to students for the 2nd and 3rd years
of study during which students complete the BTP curriculum. Innovative features include the Frontiers in
Biotechnology course that is co-taught by industry personnel; specialized Laboratory Modules in biotechnology-
techniques modeled after industry workshops; student-run Journal Club to break down discipline barriers and
promote modern data analysis fluency; leadership in campus recruiting efforts for a diverse student population
and accessibility to disabled students; an annual Symposium in Biotechnology (years 1 and 2) or BTP retreat
(every 3rd year) that each offer a Biotech Battles experience where students solve real-world problems guided
by industry experts; and targeted partnering with the Office of Professional Development for career exploration
and planning. We have established industrial partnerships to support the hallmark of our BTP, a formal internship
for all Trainees. Together, this comprehensive program prepares students well for careers in biotechnology.

Public health relevance
The ability to design, control and engineer materials and biological systems drives the development of innovative knowledge, tools and processes for advanced biotechnology in the pharma, medical devices and diagnostics industries. To achieve this goal, we must train the next generation of innovators who will be productive members of interdisciplinary teams working to translate fundamental science into products and services for human health. The UMass Amherst Biotechnology Training Program in Applied Life Sciences will continue to provide students from a variety of life sciences and engineering/physical sciences backgrounds with novel training in biotechnology, inspiring them to consider industrial relevance and translational science, and preparing them to enter the workforce with an integrated perspective about the role of biotechnology in society.